Typhoid Vaccines Targeting Both Salmonella Typhi and Its Secreted Virulence Factor

PROJECT SUMMARY / ABSTRACT
Typhoid fever is a major global health concern, with ongoing occurring outbreaks in some developing countries.
The causative agent of typhoid fever is the gram-negative bacterium, Salmonella Typhi. It has been recently
discovered that S. Typhi produces an unusual toxin known as typhoid toxin. The goal of this research program
is to generate typhoid fever vaccines targeting both the bacterium and its secreted virulence factor typhoid toxin,
and to design and specify the right-intrinsic-adjuvant system of those vaccines. In Specific Aim 1 we will
genetically engineer the Ty21a vaccine strain to make it express inactive typhoid toxin, and in Specific Aim 2 we
will generate Ty21a expressing the toxin’s receptor binding subunit without its two enzymatic subunits. In Specific
Aim 3, we will survey PltB variants to define their specific glycan binding preference, in order to specify the
adjustment on the PltB sequence, aimed at maximizing immunoreactivities of targeted age groups. The modified
Ty21a vaccines generated as part of this study are expected to be more effective and may even have potential
applications for uses in humans.

Public health relevance
PROJECT NARRATIVE Typhoid fever caused by Salmonella enterica serovar Typhi (S. Typhi) is a major global health concern with continuing outbreaks occurring in Southeast Asia and sub-Saharan Africa. Despite antibiotic therapy, typhoid fever causes ~ 200,000 deaths annually mostly among children in developing countries. Of concern is the increasing prevalence in multidrug-resistant (MDR) strains of S. Typhi in typhoid fever outbreak areas (7% of typhoid fever cases in Malawi were MDR in 2010, but by 2014, 97% were MDR). Ty21a vaccines targeting both the bacterium and its secreted virulence factor may be more effective in preventing typhoid fever caused by MDR S. Typhi.